AI + Aging (a2) Coordinating Center for the NIA Artificial Intelligence and Technology Collaboratories for Aging Research (AITCs)

The AI + Aging (a2) Coordinating Center undertakes a complementary set of activities to multiply the collective impact of the Artificial Intelligence and Technology Collaboratories for Aging Research (AITCs) to improve care and health outcomes for older Americans, including persons with dementia (PWD) and their caregivers. Building on the reputation of Rose Li and Associates (RLA) for exceptional research/event management, program coordination, and communications support services, the a2 Coordinating Center promises to establish the United States as a national connector in aging innovation, support responsible development and implementation of machine learning algorithms and datasets wherever possible, and in the process, improve the lives of millions of older Americans. The research managers and business development professionals on the a2 Coordinating Center team will work to magnify the productivity and impact of the NIA AITCs; leverage additional resources to facilitate discourse among researchers, policymakers, developers, and practitioners; and provide overarching support and advice related to all aspects of technology and business development, including ethics, navigating the regulatory and payor landscape, scaling, dissemination, and commercialization. Specific Aims are to (1) Become a national hub and catalyst for AI and aging research and development by bringing together the worlds of academia, health, venture, industry, and government to ensure the successful translation of research to application; (2) Create a culture of coordination, communication, and collaboration with the AITCs, NIA, and relevant NIA research centers and the broader scientific community; and (3) Implement a robust national infrastructure to accomplish and evaluate the multifaceted responsibilities of the a2 Coordinating Center. This national infrastructure will include capabilities for attracting pilot project applications and managing the competition process for pilot projects; providing resources and mentorship to help pilot projects realize their commercial and/or adoption potential; launching a user-friendly and engaging website to serve as a national resource for AI and Healthy Aging; creating a marketing engine to promote pilot project competitions, workshops, and industry achievements; producing both physical and virtual meetings and events; and establishing an evaluation plan with baseline and progress metrics. Establishing the a2 Coordinating Center as a dynamic hub with an entrepreneurial startup mentality outside of academic silos will generate excitement and impetus for fruitful collaborations and demonstrations of heightened impact, and will fully potentiate the success of the AITCs.

Public health relevance
The AI + Aging (a2) Coordinating Center for the NIA Artificial Intelligence and Technology Collaboratories for Aging Research (AITCs) provides strategic leadership, efficient coordination, creative dissemination, and effective project management, review, evaluation, and reporting services. The a2 Coordinating Center facilitates the matching of technologies with capital but also more importantly connects funded pilot projects with strategic and tactical guidance, resources, and mentorship. The a2 Coordinating Center activities are focused on potentiating the success of the AITCs and successfully translating research to application for the benefit of older Americans.